MRI OF POSTERIOR FOSSA NEUROVASCULAR RELATIONSHIPS

Determine the incidence of arterial compression of the right vagus nerve and right lateral medulla oblongata in patients with NIDDM in order to evaluate the hypothesis that NIDDM is a vascular compression syndrome. Show increase in incidence of left sided vascular compression upon the lower brain stem in subjects with neurogenic hypertension.